AP-MALDI source with laser post-ionization

DESCRIPTION: Significant increase in the efficiency and speed of MS-based tissue imaging (IMS) performed at atmospheric conditions using high-resolution mass spectrometer will have a profound impact on method applications to the entire analytical field of characterization of biomarkers in tissues. At present, the efficiency of the MS-based tissue imaging is limited by low sensitivity. We propose to employ a separate post-ionization step to increase the ion yield from the material ablated by laser from the tissues. To demonstrate high-throughput IMS analysis based on the proposed post-ionization technique, we plan to modify the house-built compact UV laser system capable of generation high-intensity laser pulses at very high repetition rate.

Public health relevance
Mass spectrometry (MS) analysis of tissues is currently used for profiling of known or search for new biomarkers in cancer-related studies. We plan to develop a novel method that significantly improves sensitivity, dynamics range, and throughput of MS-based tissue imaging. This high-throughput method will operate at atmospheric conditions and can be also applied for a characterization of proteins in 2D gels.